NFCR WEB SITE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The NFCR Web site provides basic information about the NFCR, descriptions of ongoing projecxts, instrument capabilities, publications, and recent news. It is also used to provide information about the Annual Course in Flow Cytometry, including agendas, maps, and registration forms. The Web site also contains information about collaboration and service activities of the NFCR, and an application form to access NFCR facilities.